ZIDOVUDINE FOR ASYMPTOMATIC HIV INFECTED INDIVIDUALS

To determine whether Zidovudine will delay or alter the progression of disease in hemophiliac patients which asymptomatic HIV infection or very early HIV induced disease.